Data Science Core

Core 2. Abstract
Data Science Core
The role of the Data Science Core is to maintain the digital data and to link to it all experimental results and
derived information (meta-data) from all participants using a relational database. Large-scale mesoscopic
imaging data, magnetic resonant imaging data, and two-photon imaging data are major part of this effort. Raw
data will be hosted, backed up, and processed locally. The data is then shifted to a central repository with
Globus access for additional high level processing across all performance sites. The Core serves to coordinate
high-level analysis. The Core also serves to disseminate the raw and meta-data and all associated software
from all studies at the time of acceptance of publications.